Neuropathology Core

ABSTRACT – ARTFL LEFFTDS Longitudinal FTLD: NEUROPATHOLOGY CORE
Neurodegenerative disease pathology has become increasingly exciting and complex in recent years. This
trend is particularly relevant to FTLD, with its many diverse and yet closely inter-related histopathological
subtypes. The overarching goals of the ALLFTD Neuropathology Core will be to (1) enhance research within
the ALLFTD consortium and (2) promote tissue-based FTLD research throughout the neurodegenerative
disease research community. The core will be led by Drs. William Seeley, Dennis Dickson, and Ian Mackenzie,
leading experts in FTLD anatomy and pathology. We aim to facilitate neuropathologic assessments and
standardized data collection on ALLFTD participants, collect standardized data across sites, and bank fixed
and frozen tissues for distribution to qualified investigators throughout the broader research community. We
will perform a pilot study of inter-rater reliability of FTLD-TDP subtypes, and incorporate a novel FTLD-TDP
module to enable standardized data collection. Finally, we will collaborate with ALLFTD researchers in the
other Cores and Projects 1 and 2 to link clinical, genetic, imaging, and biomarker data to neuropathological
data. Successful completion of these goals will have a major impact on the overall success of the ALLFTD
consortium.